Expanding access to perioperative and repurposed drug trials in melanoma and other solid tumors

Project Summary
Michael Lowe, MD, MA, Associate Professor of Surgery and Director of the Melanoma Program at Winship
Cancer Institute, seeks additional support to advance the institution’s participation in NCI-sponsored clinical
trials. His ongoing contributions, trajectory of trial participation, emerging leadership, and exciting ideas make
him an indispensable asset to Winship’s NTCN participation. Dr. Lowe is quickly become a nationally
recognized leader in surgical oncology and cutaneous malignancies, and he is driven to bring as many
concepts as possible through the NCI cooperative group mechanism. He is a member of the Winship Clinical
Council and Protocol Review and Monitoring Committee and serves as the Director the Melanoma Program
and Chair of the Melanoma Working Group. He is Clinical Director of the Morningside Center for Innovative
and Affordable Medicine, which sponsors clinical trials investigating repurposed drugs in cancer. He is a
member of the ECOG-ACRIN Melanoma and Surgical Committees and serves as the ECOG-ACRIN liaison to
the SWOG Melanoma Committee and the liaison of the Melanoma Committee to the Surgery Committee. He is
surgical chair of three NCTN clinical trials (EA6183, EA6212, and S1801) and is the ECOG champion of
S2015. He serves as site PI of S1801 and S2015 and is one of the highest NCTN enrolling investigators at
Winship. He is also site PI of numerous investigator-initiated and industry-sponsored clinical trials. Dr. Lowe
has established himself as a dedicated researcher with a special interest in advancing concepts through the
NCTN cooperative group mechanism. Over the next five years with support from this grant, he plans to
increase institutional participation in NCI-supported research and personally propose and develop two specific
trials. He will advocate for less traditional clinical trialists like surgeons, radiation oncologists, radiologists, and
dermatologists to participate in the NCTN trials. Dr. Lowe will also strongly advocate to NCTN leadership to
implement a more systemic process of patient engagement in the design of NCI-supported trials, including
patient-centered focus groups and/or surveys designed to assess the patient’s perspective on the trial design.
Given his experience in repurposed drug trials, he will advocate for disease-specific repurposed drug trials to
be opened in the NTCN committees and work towards developing a Repurposed Drug Subcommittee within
NTCN. Lastly Dr. Lowe will work with Winship CTO leadership to identify causes of NCTN trial opening delays
and work on solutions to resolve them. He is motivated to make an even bigger impact through NCI-supported
research, and this award would make a considerable impact on his ability to do so. His passion for improving
the lives of patients through clinical research make his potential capabilities limitless, and providing the
additional time provided by this award will help maximize that potential.

Public health relevance
Project Narrative Michael Lowe, MD, MA, Associate Professor of Surgery and Director of the Melanoma Program at Winship Cancer Institute seek additional support to advance his personal and the institution’s participation in NCI- sponsored clinical trials. He has an excellent track record of participation in NCTN study teams as both surgical chair and site PI and has made considerable contributions to Winship’s clinical trials program. This award would afford him additional time to propose and run clinical trials in both cutaneous malignancies and repurposed drugs and provide additional institutional resources to improve participation in and efficiency of NCI-sponsored trials at Emory.